Preventing outbreaks of foodborne pathogenic bacteria in edible sprouts via novel resistance-conferring seed treatments

Abstract
Ascribe Bioscience is developing a novel technology to prevent foodborne outbreaks caused by the
consumption of edible sprouts. Sprouts are highly vulnerable to infection with human enteric bacterial
pathogens at the seed stage. These pathogens then grow exponentially in the warm and humid conditions used
for sprouting. Even low initial bacterial counts on seeds can result in unsafe microbial loads by the end of sprout
production and processing. Moreover, the internalization of contaminating bacteria into seed tissues
contaminates the sprout tissues from inside, rendering the application of antimicrobials largely ineffective.
Sprouts have emerged as a significant source of foodborne illness and have become a public health hazard.
Between 1996 and 2017, the U.S. experienced 58 foodborne illness outbreaks associated with sprouts,
encompassing at least 1,953 illnesses, 212 hospitalizations, and 5 deaths. According to the FDA, no single
treatment so far has been shown to eliminate pathogens on seeds or sprouts that cause foodborne
illness. Ascribe Bioscience will use a natural, microbiome-derived molecule that activates and/or prime plant
defenses at the seed stage, thereby conferring to sprouts an enhanced resistance against contamination by
disease-causing bacterial pathogens. Ascribe's proposed treatment technology has the potential to
dramatically improve the safety of edible sprouts by addressing both external and internal bacterial
contamination. In Phase I, Ascribe has established the feasibility of the technology for the prevention of outbreaks
related to human consumption of sprouts by demonstrating that treatment with our molecule can prevent
Salmonella growth during the sprouting process in alfalfa. In Phase II, we will finalize the sprout seed treatment
formulation and expand testing to a broader spectrum of sprout-pathogen systems. To support
commercialization, we will perform toxicity and residue testing for regulatory approval, and refine synthesis
methodologies to enable large-scale production of the active ingredient. The specific aims of this Phase II project
are 1) Refine treatment formulation, including optimized formulation development, determination of the minimum
effective dose and treatment duration, comparison of the effectiveness of the formulation versus the sprout
industry-standard treatments, and measuring the effects of the formulation on germination, growth and sprout
quality; 2) Test the efficacy of treatments against other illness-causing pathogens on a variety of sprout types,
and evaluate it's role in altering bacterial abilities to form biofilm; 3) Demonstrate safety via toxicology studies
and residue testing to support EPA approval; 4) Develop methods to scale the synthesis of active ingredient to
pilot scale, and 5) Investigate the ability of the molecule to provide post-harvest protection to leafy greens. The
proposed research is expected to yield commercial products that will prevent or dramatically reduce the
incidence of sprout-related foodborne outbreaks.

Public health relevance
Narrative Edible sprouts pose a high risk for outbreaks of foodborne illnesses that typically originate in the seeds due to trace amounts of human enteric pathogens, which thrive under the warm, humid conditions needed for sprout production. Ascribe Bioscience is developing a novel sprout treatment product based on a natural molecule that activates plant defenses, offering reliable long-term protection against a broad range of bacterial pathogens. Successful development of this innovation has the potential to dramatically improve the safety of edible sprouts and reduce the incidence of sprout-related foodborne illness outbreaks, by uniquely conferring protection that begins at the seed stage and persists through growth, harvest, and up to the point of consumption.